Investigating the role of TDP-43 citrullination in ALS pathogenesis

MASSI/XU – ABSTRACT
Pathological molecular alteration and the associated aggregation of the TAR-DNA-binding
protein-43 (TDP-43), a protein involved in RNA processing, are hallmarks of the
neurodegenerative diseases amyotrophic lateral sclerosis (ALS) and frontotemporal lobar
degeneration (FTLD). They are also observed in a variety of other devastating neurodegenerative
diseases, including traumatic brain injury (TBI), Alzheimer's disease (AD), Parkinson's disease
(PD), and limbic-predominant age-related TDP-43 encephalopathy (LATE). Recently, we and
others have observed that, in patient protein aggregates, TDP-43 is citrullinated at two specific
sites. Protein citrullination (PC) is a common post-translational modification known to modulate
protein function. Interestingly, altered PC has been observed in various neurodegenerative
diseases including ALS, PD, AD, Creutzfeldt-Jakob disease (CJD) and multiple sclerosis (MS).
The goal of this proposal is to interrogate the hypothesis that citrullination of TDP-43 impacts its
RNA-binding activity and stability, resulting in cytoplasmic mislocalization and aggregation. We
aim to elucidate the structural basis underlying the effect of PC on both the structure, stability and
liquid-liquid phase separation (LLPS) of TDP-43 (Aim 1). We also aim to determine how
citrullination impacts TDP-43 RNA-binding activity and splicing regulation (Aim 2). Finally, we will
characterize the effect of citrullination on the nuclear versus cytoplasmic localization of TDP-43
to determine if mislocalization of TDP-43 to the cytoplasm leads to its aggregation (Aim 3).
Collectively, the outcomes from these aims will provide novel insights into the role of PC in
neurodegeneration in general and ALS in particular. The long-term goal of this research is to
utilize these molecular insights to develop TDP-43-based therapeutic strategies to treat a broad
class of devastating neurodegenerative diseases.

Public health relevance
MASSI/XU – NARRATIVE The formation of pathological TDP-43 aggregates is a hallmark of ALS and frontotemporal lobar degeneration (FTLD). For this reason, TDP-43 has been a central focus in research efforts to understand these diseases. Recent studies have shown that TDP-43 is citrullinated in patient protein aggregates. Citrullination is a common protein modification known to modulate protein function, and altered protein citrullination has been observed in various neurodegenerative diseases. The goal of this proposal is to determine if citrullination of TDP-43 impacts its function and stability in the cell, resulting in pathological aggregation. Through the proposed research, we aim to understand the molecular mechanisms by which citrullination of TDP-43 causes toxicity and dysfunction.